Computational genomic analysis of genomic variations in human tissues

Abstract
Even though all somatic cells trace their developmental lineages traced back to a single fertilized egg, during the
course of development and aging, various mutagenic exposures, DNA replication errors, and imperfect DNA
repair lead to accumulation of somatic mutations – resulting in genetic variations among somatic cells in a tissue.
While somatic mutations have primarily been investigated in the contexts of phenotypic conditions such as
pigmentation patterns, diseases such as cancer, autoimmunity etc, or disease precursors such as field
cancerization and clonal hematopoiesis, emerging evidence suggests that somatic mutations in apparently
healthy tissues might be more common than previously anticipated, and that clonal makeups of somatic tissues
continue to evolve throughout the lifetime. Nonetheless, our understanding of the patterns of ‘normal’ somatic
variations in pathologically normal tissues remains limited –in terms of the types of tissues affected, classes of
genomic alterations, and their etiologies – in part, due to technological barriers. In particular, many types of
genomic alterations in mosaic somatic tissues remain poorly characterized. Recent technological developments
have enabled examining complex patterns of genomic alterations and their significance in tissue contexts at
unprecedented resolution and high accuracy. Here, utilizing emerging genomic technologies and computational
genomics resources, and focusing on organs that have different types of exposure and regeneration abilities,
we will ask two related questions: What are the prevalence and patterns of somatic genomic alterations in
pathologically normal tissues? To what extent such genomic alterations contribute towards transcriptomic and
phenotypic variations at the cellular and tissue-level? This research contributes towards understanding the
landscape of somatic variations in pathologically normal tissues in human. Regularity of healthy tissues is taken
for granted, which under-appreciates the genetic and non-genetic variations within. Our efforts have potentials
to challenge the dogma, that have relevance for development, aging, and many disease types including cancer,
immune and neurological disorders. Importantly, it will provide us with a baseline to compare the alterations
observed in disease and pre-disease conditions, which would have implications for early detection, disease
prevention, and minimizing over-diagnosis. We will also develop computational genomic resources contributing
towards reproducible research and community-level resource sharing for advancing our understanding of
somatic variations in human tissues.

Public health relevance
Narrative This study will develop resources to study patterns of somatic genomic alterations in pathologically normal human tissues. The landscape of somatic alterations in healthy tissues can help distinguish those more likely to be associated with aging and early disease progression, which has relevance for prevention and early detection of multiple types of diseases.